Bacterial anti-inflammatory lipid mediators

Project Summary
The rapid response of the innate immune system to infections relies on the detection of pathogen-associated
molecular patterns (PAMPs), such as lipopolysaccharides, that activate a robust inflammatory response to
invading organisms. My research program focuses on an unappreciated countermeasure deployed by
commensal bacteria and pathogens that attenuates the immune response to PAMPs. Oleate hydratase (OhyA)
is an enzyme that is expressed in commensal bacteria and the important human pathogen Staphylococcus
aureus. OhyA stereospecifically hydrates the 9-cis double bond of unsaturated fatty acids to produce 10-
hydroxy-fatty acids (hFAs); however, bacteria expressing OhyA do not synthesize unsaturated fatty acids.
OhyA substrates are only encountered at the interface of host tissues, where unsaturated fatty acids are
abundant. I hypothesize that hFAs produced by commensal or pathogenic organisms serve as signaling
molecules that blunt the innate immune response to PAMPs. Indeed, S. aureus ohyA knockouts fail to
establish infections in mice, illustrating the importance of OhyA and hFAs to S. aureus virulence. Thus, hFAs,
which were first discovered in the gut microbiome, may provide an important mechanism for commensal
bacteria to attenuate gastrointestinal inflammation and create tolerant, symbiotic environments. My pilot
experiments and some previous reports provide preliminary evidence for the anti-inflammatory action of hFAs,
but the mechanism(s) of immune suppression by hFAs are unknown. To address this shortcoming, I will
receive formal immunology instruction through coursework and hands-on training in the laboratory of Dr. Paul
Thomas, an expert immunologist, during the K99 phase. We will determine whether hFAs directly antagonize
extracellular PAMP binding to immune cell receptors, bind to CD1 lipid-presenting molecules for T-cell receptor
recognition to antagonize T cell activation, or intercept signaling downstream of PAMP-receptor activation by
stimulating G-protein coupled receptors and/or PAPR. The results of these experiments will uncover the
mechanistic basis for hFA modification of immune cell responses. OhyA has no mammalian homolog, and
validating the importance of OhyA for virulence coupled with the X-ray structures of OhyA will provide the key
information required to determine whether OhyA is a candidate target for antimicrobial drug discovery. During
the R00 phase, I will test the hypothesis that OhyA is packaged into extracellular vesicles released by S.
aureus to interact with surrounding host tissues to form a halo of hFA mediators around the infection site. My
findings will provide an atomistic mechanistic understanding of how OhyA binds to and influences membrane
structure to promote vesicle formation. The K99/R00 research plan is designed to leverage my expertise in
biochemistry and structural biology, while receiving new training in immunology, to advance the understanding
of immune regulation by bacteria and launch a productive and successful career in which I will lead a research
program to elucidate the role bacteria lipid products play in controlling host responses.

Public health relevance
Project Narrative Lipid mediators are major signaling molecule constituents in all kingdoms of life, and bacteria produce bioactive lipid mediators that are not made by mammalian cells. Inflammation in the intestine or sites of bacterial infections exemplifies the immune response to agonistic bacterial lipid mediators, but some bacteria also produce lipid countermeasures, such as hydroxy fatty acids, that can suppress the inflammatory response. This project will elucidate the immune signaling pathways that respond to hydroxy fatty acids to suppress immune responses and the biosynthetic pathways by which commensal and pathogenic bacteria release hydroxy fatty acids.